Core F: Imaging Biomarker Core

NEUROIMAGING CORE - CORE F: PROJECT SUMMARY/ABSTRACT
The Neuroimaging Core (Core F) of the Johns Hopkins Alzheimer’s Disease Research Center (JHADRC) has
several overarching goals. It is responsible for collecting, processing, and sharing brain images acquired from
participants in the JHADRC, and the data derived from them, as well as assisting in the disclosure of clinically
relevant findings from the scans to participants. The Core is also responsible for providing expertise to
investigators conducting imaging research in ADRD, for assisting in training young investigators in the
application of these valuable resources, and for providing education to the lay community about the importance
of brain imaging in finding improved treatments for ADRD. To accomplish these goals, the Neuroimaging Core
will focus on the following aims: 1) to acquire magnetic resonance imaging (MRI) scans as well as amyloid and
tau positron emission tomography (PET) scans from participants enrolled in the JHADRC (working with the
Clinical Core (Core B) , 2) to complete quality control procedures and incorporate all newly acquired scans into
the existing MRI and PET scan repository, and to upload the relevant scans to the NACC, SCAN, CLARiTI and
other multicenter studies in which the JHADRC is participating (e.g. DVCID), 3) to provide investigators both
internally and externally with raw images and image analysis results based on established validated image
analysis methods, including novel imaging measures developed by the members of Core F, 4) to use the
JHADRC database (overseen by the Data Core) to track the acquisition, processing and distribution of each
scan, 5) to facilitate the disclosure of the clinical interpretation of MRI and amyloid PET scans to JHARDC
participants, 6) to provide expertise and mentoring to investigators interested in using neuroimaging data,
including those in the REC, and 7) to provide education in the community regarding the importance of
neuroimaging in ADRD, in collaboration with the ORE Core (Core E). Through these efforts, Core F strives to:
1) support investigators associated with the JHADRC with key resources, 2) provide expertise and mentoring
to both junior and senior investigators working in AD and related disorders, and (3) promote an understanding
of the importance of brain imaging for clinical and translational research in the field.